Neurophysiology Component - Roberto

Abstract

Our TSRI-ARC has focused on preclinical work on the cellular, neurochemical, and molecular mechanisms of
alcohol dependence, with a major interest in the role of the central nucleus of the amygdala (CeA) in excessive
alcohol drinking. However, there is a great need to understand the mechanisms that mediate dependence-­
induced drinking motivated directly by withdrawal/abstinence symptoms. The Neurophysiology Project will
continue to study the neuroadaptations induced by alcohol dependence in the CeA, and will now investigate
upstream neuronal circuits that are responsible for dysregulation of the CeA during alcohol abstinence.
Corticotropin-­releasing factor (CRF) and CRF1 receptors are involved in the ethanol-­induced increase in GABA
release in the CeA and the CRF system is upregulated after ethanol dependence. Chronic CRF1 antagonism
blocked alcohol dependence-­induced increases in ethanol consumption. Notably, the transition to alcohol
dependence also dysregulates executive function, and the infralimbic (IL) subdivision of the mPFC exerts “top-­
down” control over the amygdala to regulate emotional aspects of goal-­directed behaviors. Thus, this renewal
application focuses on the overall hypothesis that ethanol dependence and withdrawal are driven by the
recruitment of CRF and serotonin (5-­HT) signaling in cortical-­amygdala circuits. We will study neural function
during ethanol abstinence and characterize how long those neuroadaptive changes persist. In particular, our
goal is to characterize neuroadaptations in the CRF and 5-­HT systems and their effects in the CeA and IL
through common cellular systems to induce a maladaptation in neural function that promotes ethanol
withdrawal-­induced anxiety-­like behavior. Our project is designed to test the hypothesis that dependence and
withdrawal (early withdrawal = 2-­8 h;; late withdrawal = 2 weeks) differentially alter responses to 5-­HT and CRF
in CeA neurons (Specific Aim 1) and will affect the excitability of IL pyramidal neurons in layer V that project to
the CeA (Specific Aim 2). Finally, Specific Aim 3 will electrophysiologically assess the ethanol-­induced
synaptic and molecular mechanisms of candidate drugs that are identified and tested in preclinical animal
models (Contet and Animal Models Core) and subsequently tested in the clinical component (Mason). The
project will use IL and CeA brain slices and standard whole-­cell patch-­clamp and cell-­attached
electrophysiological methods, as well as measures of protein levels and chemogenetic and behavioral testing
that will involve continued collaboration with the George/Zorrilla, Contet, Martin-­Fardon, and Mason projects
and Animal Models Core. It is imperative to provide data that elucidate the cellular basis of the susceptibility of
alcoholics to stress and relapse. A better understanding of the neuroadaptations that shape the synaptic
networks that are involved in ethanol dependence represents a challenge to alcohol researchers and will lead
to the development of new therapeutic agents to alleviate alcohol dependence and prevent relapse.

PHS 398/2590 (Rev. 06/09) Page Continuation Format Page